BoostOne

PROJECT SUMMARY Individuals with opioid user disorder (OUD) face both short-term and long-horizon challenges to healthy and productive decision-making. Recovery, particularly in the setting of MAT (but also more generally), is deeply affected by phasic/psychological cravings and impaired long-horizon decision-making. Current cravings- avoidance tools suffer from limited usability and restricted utility in common environmental/social contexts. In addition, the majority of introspective or self-control improvement strategies (mindfulness, CBT) are unsuited for uptake during moments of vulnerability, while clinical counseling or peer support suffer from scale/access limitations. In response, we propose a field-deployable (mobile smartphone), automated intervention for acute cravings in OUD which simultaneously addresses neurobiological drivers of long-term impulsive decision- making. The innovation (“BoostONE”) comprises a system for just-in-time cravings management (Boost-C) and impulsivity mitigation (Boost-I) and includes a framework for psychometric measurement of executive function for outcomes tracking. Predicted effects of usage by individuals in MAT will be evaluated in a feasibility study of the validated package. We anticipate this Phase I SBIR will provide the foundation for deployment of BoostONE in active treatment settings and for broader extensions of the underlying technology framework.

Public health relevance
PROJECT NARRATIVE Opioid use disorder (OUD) and related conditions are extremely damaging to individuals and society. Cravings and impulsivity are key contributors to OUD relapse which remain underserved by current treatments/tools. We propose to address both key contributors, in parallel, under a common theoretical framework, via a novel smartphone intervention (“BoostONE”).